Development of a prototype for a mobile health intervention for smoking cessation with features culturally adapted for African American smokers

PROJECT SUMMARY/ABSTRACT
The success rate of smoking cessation without any form of assistance is less than 10%, and rates are
even lower among African American (AA) smokers (3.3%), who suffer worse health consequences. Therefore,
it is critical to have interventions that particularly take AA smokers’ needs into account. Mobile health (mHealth)
technology, a growing area of healthcare, shows promise in smoking cessation, and can be used to augment
traditional smoking cessation treatment options such as pharmacotherapy or counseling. However, studies on
culturally adapted mHealth interventions for AA smokers are lacking. More research is needed to determine
how to make mHealth interventions more appealing to users and increase uptake by culturally adapting
features such as contents type and delivery, design features, and other engaging elements.
The goal of the proposed project is to develop the prototype of a mHealth application (app) for smoking
cessation with features that are culturally adapted for AA smokers. The project will be successfully conducted
under two aims: 1) Determine optimal content and design features of mHealth apps for smoking
cessation are most preferred by adult AA smokers. I will develop and refine a list of preferred mHealth
content and design features from the literature through focus groups with AA smokers. I will use feedback from
the focus groups to conduct a discrete choice experiment (DCE) with hypothetical apps created with preferred
content and design features to further refine the list based on level of importance. 2.) Apply user-centered
design to develop a prototype of a mHealth app with content and design features rated as most
preferred by AA smokers, followed by formative evaluation by end-users to ultimately develop final
design specifications. I will develop the prototype (revisable version) of the mHealth app using a prototyping
software. I will then conduct formative evaluation to evaluate workflow, user experience and perceived usability
in an iterative manner with revisions and then create a set of documents with page for all components of the
app and flowcharts which will be used to communicate with developers for the final product.
The proposed research and training will propel me toward my career goal of becoming an independent
scientist mHealth interventions, with a focus on health equity by developing expertise in nicotine addiction and
cessation science, experimental designs such as discrete choice methodology, user-centered design with
cultural adaptation and the development of mHealth interventions for AA smokers. This proposal is responsive
to NIDA’s commitment to health equity and to developing new treatments for substance use disorders.
Findings from this study will prepare me to conduct a future large-scale randomized trial comparing the new
mHealth app versus a generic app such as QuitGuide.

Public health relevance
PROJECT NARRATIVE Current research suggests that mobile health interventions have been successful in leading to behavior change but African American smokers have not been well represented in mobile health intervention studies for smoking cessation despite having lower success with cessation when compared with other racial groups. This project develops the prototype of a mobile health app with features that are culturally adapted for African American smokers, which may lead to increased uptake, aimed at improving successful smoking cessation in this underserved population.